Role of Vitamin D Metabolism in CRS

Chronic rhinosinusitis (CRS) affects 16% of the United States' population with few proven treatments.
CRS with nasal polyps (CRSwNP) is the most difficult form of the disease to treat and has a negative impact
on quality of life that exceeds other chronic conditions, such as heart failure and chronic obstructive pulmonary
disease. CRSwNP is characterized by a type 2 skewed inflammatory profile and increased numbers of
sinonasal fibroblasts. Given its anti-inflammatory properties, vitamin D3 (VD3) may serve as a potential novel
treatment for CRSwNP. We have shown that patients with CRSwNP have alterations to the vitamin D system
that extends beyond a simple nutrient deficiency caused by diet or lifestyle. CRSwNP patients have reduced
sinonasal levels of the active metabolite of VD3, 1,25(OH)2D3, despite adequate circulating forms of its
precursors or 1,25(OH)2D3 itself. Furthermore, reductions in human sinonasal epithelial cell (HSNEC) levels
of 1α-hydroxylase, the enzyme responsible for the final hydroxylation to make 1,25(OH)2D3, is associated with
more severe CRSwNP. The scientific premise of these studies is to determine if increasing local levels of
1,25(OH)2D3 can reduce sinonasal inflammation and serve as a potential treatment for CRSwNP. In
preliminary studies, we observed that 1,25(OH)2D3 reduced human sinonasal epithelial cell (HSNEC) and
sinonasal fibroblast (HSNF) production of type 2 mediators. While HSNF can respond to 1,25(OH)2D3, they
are not capable of metabolizing it themselves, leaving them dependent on other cell types, mainly HSNECs,
as a source of 1,25(OH)2D3.
Based on these and other data, we hypothesize that impaired 25(OH)D3 metabolism by HSNECs
results in local deficiencies in 1,25(OH)2D3, thereby driving the type 2 inflammation and fibroblast activation
associated with CRSwNP. We will test this hypothesis through the execution of the following aims. Aim 1
will examine the contribution of 25(OH)D3 metabolism to HSNEC-derived inflammation and determine the
ability of 1,25(OH)2D3 to modulate endogenous and exogenously-stimulated inflammation by control and
CRSwNP HSNECs. In Aim 2 we will determine the role of human sinonasal epithelial 25(OH)D3 metabolism
and 1,25(OH)2D3 in the regulation of fibroblast-derived inflammation. In Aim 3 we will test, in vivo, how
alterations in sinonasal vitamin D metabolism regulates inflammation and disease severity utilizing a murine
model of atopic CRS. With respect to outcomes, these studies will greatly expand our understanding of how
local 25(OH)D3 metabolism regulates sinonasal inflammation and will test the feasibility and potential efficacy
of sinonasal delivery of 1,25(OH)2D3 as a treatment for CRSwNP. In addition to the direct applicability of
these findings to CRSwNP, our results may be relevant to other respiratory diseases, most notably to asthma
and allergic rhinitis.

Public health relevance
This proposal will investigate the role of impaired metabolism of vitamin D3 by sinonasal epithelial cells and how it contributes to the inflammation associated with chronic rhinosinusitis with nasal polyps. These studies will also test the efficacy of intranasal vitamin D delivery in a murine model of chronic sinusitis.